Myeloproliferative Neoplasms-Research Consortium

Overall Abstract Myeloproliferative Neoplasm- Research Consortium
P.I. Ronald Hoffman M.D.
The Myeloproliferative Neoplasm Research Consortium (MPN-RC) is an interactive group of laboratory,
translational and clinical scientists from 13 institutions who have worked for almost 14 years in a coordinated
fashion to develop and evaluate therapeutic strategies aimed to improve the survival of patients with
myelofibrosis (MF). The MPNs, including polycythemia vera, essential thrombocythemia and primary MF, are
clonal hematological malignancies which originate at the level of the hematopoietic stem cell. We will continue
to focus our efforts on MF since it is the MPN associated with the shortest survival and at present allogeneic
stem cell transplantation is the only curative therapeutic modality. Unfortunately, over 90% of MF patients are
not candidates for stem cell transplantation. The only currently approved therapy for MF is first generation JAK2
inhibitor therapies, which have not proven to be disease modifying. Approximately one half of patients
discontinue JAK2 inhibitor therapy within 3 years and three-fourths by 5 years. The median survival after
discontinuation of JAK2 inhibitor therapy is approximately 14 months. The limitations of first generation JAK2
inhibitor therapy can be attributed to its inability to selectively attenuate the fitness of MF clonal hematopoietic
stem cells. The overall strategy of the MPN-RC is based on the hypothesis that although MF is uniformly
associated with activation of the JAK/STAT signaling pathways, that increased clinical benefit for MF patients
will require the implementation of novel therapeutic strategies, which utilize combinations of drugs that interrupt
dysregulated interacting cellular pathways and deplete or eliminate MF stem cells by directly targeting
vulnerabilities in MPN stem cells and/or their interplay with the MF microenvironment. Based on discovery
science and preclinical therapeutic studies, rationally designed therapies will be evaluated in rigorous,
independent, investigator-initiated clinical trials, which will address key scientific hypotheses and therapeutic
questions, which ultimately will prolong the overall survival of MF patients. In order to implement this overall
strategy the following Specific Aims will be pursued: Aim 1: To identify and credential therapeutic strategies
which deplete or eliminate MF HSCs by directly targeting malignant MF HSCs and/or their interplay with their
tumor microenvironment. Aim 2: To rationally design and rapidly execute preclinical studies and investigator-
initiated scientifically based phase 1/2 clinical trials with embedded biomarker studies, which assess our ability
to attenuate the fitness of MF HSCs through stem cell and tumor microenvironment-targeting therapies. Aim 3:
Actively and dynamically maintain a collaborative translational research network that supports and synergizes
the laboratory and clinical studies led by MPN-RC investigators.

Public health relevance
Project Narrative - Overall The Myeloproliferative Neoplasm Research Consortium (MPN-RC) is an inter-active group of laboratory and clinical scientists from 13 institutions who work in a coordinated fashion to develop and evaluate therapeutic strategies that will improve the survival of patients with myelofibrosis (MF). We hypothesize that combinations of drugs which act by directly targeting malignant hematopoietic stem cells and/or by correcting their tumor promoting micro-environments can be used to deplete the numbers of cancer stem cells. The overall goal of the MPN-RC is to employ the complementary skills and efforts of its scientifically diverse membership to generate the scientific foundation for novel therapeutic strategies which will be evaluated in rigorous, well- constructed independent investigator-initiated clinical trials to prolong the survival of MF patients.